Functional Analysis of Whole-Brain Dynamics in Learning

PROJECT SUMMARY
Learning is a complex process, and likely involves many areas of the brain that detect and process sensory
inputs, integrate experience, and display behavior. Consistently, various neurological diseases that impair
different brain areas are associated with profound defects in learning. Thus, bridging different spatial scales
and understanding the dynamics of different brain regions are essential to understanding how learning occurs
and potentially designing strategies to mitigate learning deficiency. However, it is currently not possible to
achieve these goals in most experimental systems, and our understanding of learning is limited by the
technical approaches by which either local circuit and cellular properties or coarse psychophysical
parameters underlying learning are measured. Here, we propose to address these fundamental questions in
a reduced system – the nervous system of the nematode C. elegans. The rationale is that the wiring and
genetic make-up of this network are well known, probing whole-brain dynamics with single-cell resolution
with exquisite temporal resolution is technically ready for C. elegans, and the fundamental principles for the
development and the function of the nervous system are well conserved between C. elegans and more
complex animal models. Further, C. elegans exhibits many forms of learning, similar to those displayed by
higher organisms in behavioral characteristics and molecular cellular underpinnings. Particularly, we will use
an olfactory learning paradigm whereby C. elegans learns to avoid the odorants of pathogenic bacteria, a
type of learning similar to the Garcia effect through which many animals, including humans, learn to avoid
the smell and/or taste of a food that makes them ill. Our long-term goal is to understand how learning is
encoded and executed by the function of the whole brain, and to inform the design of potential therapeutic
strategies. The central hypothesis of this project is that learning engages global activity and the learned
information is encoded in distinct functional modules. Specifically, we will test whether learned information
is encoded in the learning-dependent changes in the activity patterns of individual functional modules and/or
the interactions among the modules. To this end, we aim to image and analyze multi-cell and whole-brain
dynamics under naive and learned conditions to characterize how learning alters the structure of the brain
activities; further, we will introduce perturbations to the whole-brain dynamics and examine the consequences
for learning. This work is innovative because (1) it brings a conceptual advance to understanding learning
across scales, (2) it introduces technical advancement in whole-brain imaging and analyses, and (3) it
demonstrates perturbation strategies for altering whole-brain dynamics that have behavioral consequences.
It is significant, because it tests several highly plausible and likely conserved cellular and whole-brain
dynamic models for learning and examine their behavioral consequences, it informs and facilitates learning
studies in other systems, and it paves the way for designing interventions.

Public health relevance
PROJECT NARRATIVE The neural basis of learning is complex, which likely involves the activities of many brain areas whose malfunctions are associated with impaired learning ability in various neurological diseases that adversely affect communication. This project studies how learning is encoded by the dynamic activity of the nervous system at the scale of whole brain with the resolution of individual neurons. The outcome of the proposed study will contribute to our integrative understanding of how learning is regulated by the brain function across scales, inform learning studies in more complex brains, and guide potential design of therapeutic strategies.